Senior Leadership

The Senior Leadership of the Cancer Center is responsible for all major decision-making and activities within the Center. The Cancer Center Director, his Deputy Director, five Associate Directors, and the Director of Scientific Programs Administration (described in Section 7.6) make up the top leadership group, the Directors Group. The Assistant Directors join this group at the quarterly Cancer Center Leadership Retreat. Funding is requested for salary support for each senior leader commensurate with his/her role within the Cancer Center.